The role of eosinophil in thrombosis and atherosclerosis in LNK deficiency

Project Summary/Abstract
Atherothrombotic cardiovascular disease (ACD) remains the major cause of morbidity and
mortality in the US. Increased number and activation of neutrophils and eosinophils are
associated with increased risk of ACD. The underlying mechanisms of these associations are
incompletely understood, and no therapies specifically address these risk factors. Human GWAS
have unraveled association of a common polymorphism of LNK/SH2B3 (T allele, R262W) with an
increased risk of ACD and increased neutrophil, platelet and eosinophil counts. This LNK variant
is carried by ~75% European, ~50% Latin American and ~30% African American populations. We
have shown that LNK(R262W) reduces LNK function and LNK deficiency in blood cells promotes
atherosclerosis in mouse models. More recently, we have shown that enhanced neutrophil
extracellular trap formation promotes atherothrombosis in Lnk-/- mice. Mechanistically, activated
LNK deficient platelets present increased oxidized phospholipids, priming neutrophils for NETosis.
While eosinophils represent a small fraction of white blood cells, there is accumulating evidence
that they play an important role in thrombosis and atherosclerosis. We have preliminary data
showing prominent eosinophilia and reversal of accelerated thrombosis in Lnk-/- mice by antibody
mediated eosinophil depletion. The preliminary data suggests a major role of eosinophils in
eosinophil, neutrophil and platelet interactions that promotes thrombosis in hematopoietic Lnk-/-
mice. The broad goal of this project is to investigate mechanisms connecting LNK deficiency to
atherosclerosis and thrombosis. A major new hypothesis is that hematopoietic LNK deficiency
promotes arterial thrombosis, plaque erosion and atherosclerosis at least in part via increased
eosinophil production, eosinophil activation and interaction with platelets and neutrophils. In this
proposal, we will follow the leads and generate novel mouse models including a mouse line with
floxed Lnk to explore the mechanisms underlying the role of eosinophils in atherosclerosis and
atherothrombosis in hematopoietic LNK deficiency. A better understanding of these mechanisms
may lead to development of new therapeutic approaches to managing ACD risks, probably in
populations with defined genetic background, e.g. LNK(R262W) polymorphism.

Public health relevance
Project Narrative This project is aimed to explore the mechanisms underlying increased risk of atherothrombosis driven by LNKW262R, a common genetic polymorphism that is associated with increased cardiovascular events, using both animal models and human blood cells.